ENDOCRINE & METABOLISM TRAINING GRANT

We seek support for the continuation of a highly successful, multi-center and multi-departmental training program
at UT Southwestern Medical Center that provides M.D. and Ph.D. trainees with a firm basis in state-of-the-art
methodologies, in addition to preparing them for future academic careers in metabolism research. The program
under the auspices of this T32 has been running for the past 44 years. Established investigators from several
Departments and a number of Centers join forces to provide our trainees with a multi-facetted and diverse
training program. Participating Centers include the Touchstone Center for Diabetes Research, the Center for
Hypothalamic Research, the Center for Human Nutrition, the Advanced Imaging Research Center, the
McDermott Center for Human Genetics, Center for the Genetics of Host Defense and the Simmons Cancer
Center. Areas of expertise include systemic and cellular metabolism, diabetes, lipid biosynthesis, obesity, human
genetics related to metabolic disorders and tumor metabolism. Our T32 mentors direct highly competitive
research programs of national and international stature. Our trainees can take advantage of a very strong
research infrastructure that allows them to address physiological, biochemical and cell biological problems with
emerging technologies and the latest instrumentation. The 56 mentors are chosen from a tightly interwoven,
highly integrated group of investigators, which cover all of the relevant areas in metabolism research and a
number of sub-specialties in endocrine research. Metabolism research at UT Southwestern has flourished over
the past 15 years, due to the programmatic expansion over the previous period from 2007-2022. The school has
made a major commitment towards complementing existing areas of expertise by targeted recruitment of key
personnel to fill existing gaps over the past decade. Here, we build upon the historic strengths of our training
program, while taking advantage of the programmatic expansion experienced at UT Southwestern. This T32 is
an important cornerstone of metabolic research at UT Southwestern. We have implemented a number of
changes that have proven highly successful to further improve the quality of our training experience. During the
previous funding period (2018-2022), 7 trainees completed the program, or are currently in the program; most of
which have successfully applied for external funding. The current epidemic of obesity and its pathophysiological
sequelae is on an exponential rise. It is paramount to train the next generation of metabolism researchers and
endocrinologists to cope with this enormous public health problem, and further, to develop innovative approaches
to combat metabolic dysfunction. Furthermore, we now appreciate that we are facing a serious public health
issue in light of the fact that Covid-19 further increases the potential to become a type 2 diabetic risk if certain
factors are already present at the time of infection. We aim to train the next generation of researchers that will
be able to successfully shed light on the mechanistic basis for metabolic dysregulation in this context.

Public health relevance
Endocrine disorders such as diabetes, obesity, dyslipidemias, thyroid disease and polycystic ovarian syndrome are all associated with enormous costs; both with respect to their morbidity and mortality and their burden on the health care system. This proposal aims to provide resources that train young investigators at the MD or PhD level who will play a key role in extending our understanding of basic metabolic processes at the subcellular, cellular, organ and system level. Moreover, translating these new insights into both mechanistic and translational advances for disorders related to metabolic dysfunction.